Occupational Safety and Health Research (R01)

Immigrant Latinos experience elevated rates of occupational fatality, injury and illness within the
construction industry, particularly within the small-scale residential construction industry. Safety initiatives in
residential construction focus on workers: the involvement of contractors and other sources of influence like
family members remains a critical oversight to long-term sustainability of safety initiatives. The overall goal
of the proposed research is to create capacity for sustained commitment to worker safety among small­
scale residential construction contractors employing Latino workers. The project goal will be achieved
through a community-based partnership of academic researchers, the Greater Tulsa Hispanic Chamber of
Commerce and a translational research project that will accomplish three specific aims: 1) document
strengths, weaknesses, opportunities and threats of contractors in small-scale residential construction to
enhancing fall prevention initiatives with their workers; 2) describe beliefs held by family members about
the risks Latino construction workers encounter on the job, the modifiability of those risks, and the ability
family members have in minimizing those risks; 3) determine the added impact of a "Lay Health Advisor"
(LHA), "employer enhanced" and "family-enhanced" intervention strategy in comparison to a control group
that receives written safety education alone. These aims will be accomplished through a mixed-method
design focused on Research-to-Practice (R2P). Aims 1 and 2 will be accomplished through the collection
and analysis of qualitative in-depth interview data with Latino contractors (Aim 1) and family members of
Latino workers (spouses most likely, Aim 2). Aim 3 will be accomplished through a community-based trial
where N=40 contractor crews (consisting of 4-6 workers/crew) are the basis for randomization. Crews will
be randomly assigned to one of four conditions: treatment as usual (worker education by a Lay Health
Advisor (LHA)), employer-enhanced treatment (worker education by LHA combined with contractor/crew­
leader safety training}, family-enhanced treatment (worker education by LHA combined with family safety
training), and a control group (written safety education alone). Determination of the added impact of the
employer- and family enhanced strategies will focus on differences in pretest-posttest and follow-up
changes in core safety behaviors.
RELEVANCE (See instructions):